Antibody mediated immunity against Klebsiella pneumoniae

PROJECT SUMMARY
Klebsiella pneumoniae has emerged as a critical human pathogen in the United States and globally. In
the United States, K. pneumoniae is the third most common cause of hospital-acquired infections and accounts
for 20% of deaths attributable to antibiotic-resistant bacteria. In low- and middle-income countries, K.
pneumoniae is a leading cause of childhood mortality and neonatal sepsis. Despite the rising importance of
this pathogen, there are no U.S. Food and Drug Administration or World Health Organization-approved
vaccines for K. pneumoniae.
Our project is designed to address three critical knowledge gaps related to the development of Klebsiella
vaccines. First, although a quadrivalent O-antigen vaccine for K. pneumoniae has been proposed, there is
insufficient evidence to show that the inclusion of only four O-types would provide sufficient protection against
the nine structural subtypes of these K. pneumoniae O-antigens. To address this knowledge gap, we will
determine whether human infection with each K. pneumoniae O-antigen subtype results in cross-specific
antibody responses against other K. pneumoniae subtypes. This research will provide new and detailed
information on the specificity of human O-antigen responses to K. pneumoniae and inform the antigenic
composition of a K. pneumoniae O-antigen vaccine. Second, our proposed experiments will determine which
K. pneumoniae antigens contribute to functional human antibody responses the bacterium. Specifically, we will
determine whether antibody responses to both the capsular (K-) and O-antigens the bacteria through
interactions with phagocytic cells and complement. This is important because such functional responses are
likely to mediate protection against K. pneumoniae infection. Third, we will determine which types of
antibodies are associated with protection against intestinal colonization with K. pneumoniae. If we identify
antibodies that are correlated with protection against K. pneumoniae, this will represent a groundbreaking
finding and aid in the development of vaccines for this important pathogen.
In summary, we expect the proposed studies to generate fundamental insights into immunity against this
pathogen and aid in the development and assessment of K. pneumoniae vaccines. Our proposed work will
provide critical data to inform the antigenic composition of K. pneumoniae vaccines and new proxy measures
to assess vaccine efficacy in pre-clinical and early phase vaccine trials. These insights are urgently needed to
address the growing global threat of antibiotic-resistant K. pneumoniae.

Public health relevance
PROJECT NARRATIVE Klebsiella pneumoniae is a leading cause of antibiotic-resistant hospital-acquired infections and childhood mortality. In this study, we will determine what types of antibodies are associated with protection against Klebsiella pneumoniae. We will also study human antibody responses against a variety of molecules that coat the outer surface of Klebsiella pneumoniae to identify the ideal targets of a new vaccine for this bacterium.